Statistical and Machine Learning Methods to Address Biomedical Challenges for Integrating Multi-view Data

Project Summary
Many diseases are complex, heterogeneous, conditions that affect multiple organs in the body and depend on the
interplay between several factors that include genetic, cellular, molecular, and environmental factors. It is therefore
not surprising that the pathogenesis of many complex diseases remain elusive, and therapeutic targets are lacking.
The traditional approach that focus on a small number of molecules (e.g., genes or metabolites) or a single type of
data (e.g., clinical or genetic) cannot address this complexity and heterogeneity. Integrative or systems biology
approaches and network analysis can be used to leverage the strengths of data from multiple sources (e.g.,
genomics, metabolomics, epidemiology, clinical data) to achieve new insights into the pathobiology of complex
diseases. Recent technological advances have enabled the production of vast amounts of diverse but related data
with rich information that offer remarkable opportunities to understand biological processes involved in complex
diseases and to transform medicine, yet at the same time present signiﬁcant analytical challenges including how
to effectively synthesize information from the tens of thousands of data points to identify important biomarkers
with potential to serve as therapeutic targets. To alleviate this, we will develop and apply a suite of novel, robust,
and powerful statistical and machine learning methods for the integration and interpretation of cross-sectional and
longitudinal data from multiple sources. These models will also be used to deﬁne subpopulations of patients who
have different prognoses or require different therapeutic approaches based on data from different sources. Further,
we will make use of recent advances in network theory to model the complex multilateral relationships in molecular
data from multiple sources. The proposed methods will be applied to several publicly available datasets and cohorts
to ensure that we can generalize our work to other datasets and cohorts and thus increase the long-term impact
of our research. The proposed research will also contribute valuable statistical and machine learning algorithms
that will be broadly applicable to data from multiple sources and multiple cohorts and will be made available to the
public free of charge.

Public health relevance
Project Narrative This proposed research is expected to lay the foundation for advances in disease diagnosis, treatment, and personalized care through the integration and interpretation of cross-sectional and longitudinal data from multiple sources; it will contribute valuable tools and methods with potential for identiﬁcation of novel molecular targets for therapeutic interventions and for discovery of novel disease subtypes for improved patient prognosis.